ProMoTr: A Proteomics Center for MoTrPAC

PROJECT SUMMARY
Although the health benefits of physical activity in the prevention and mitigation of many chronic diseases have
been documented for decades, the molecular mechanisms mediating these health benefits are still poorly
understood. To understand the adaptive response of physical activity at the molecular level, it is essential to
comprehensively characterize the dynamic changes in protein expression and post-translational modifications
(PTMs) in. The overall objective of the PNNL Proteomics Chemical Analysis Center is to support the
consortium by providing comprehensive discovery of proteins and associated PTMs in skeletal muscle and
subcutaneous adipose tissues collected by Clinical Centers of MoTrPAC. To aid in the development of a
‘molecular map’ of transducers that provides the critical insights and molecular impacts of physical activity in
humans, our integrative proteomics analysis plan focuses on two major tissues known to be important in
exercise signaling especially with training adaptations. This work will intracellular signaling as mediated by
protein PTMs, including protein phosphorylation, lysine acetylation, and pilot studies of reversible redox
modifications. The High level summary of the Specific Aims of this project are: 1) Analyze and publish
expansive multi-omics datasets in a collaborative manner. 2) Collaborate with CC investigators and the rest of
MoTrPAC to implement temporal multi-omics profiling of muscle and adipose tissue following an acute
exercise bout in highly active adults. 3) Perform state-of-the-art proteomics profiling based on the human tissue
analysis plan. 4) Coordinate with other MoTrPAC activities including efforts under the CCC, inclusive of the
1) Administrative Coordinating Core (ACC), 2) Data Management, Analysis, and Quality Control Core
(DMAQC), 3) Exercise Intervention Core (EIC), and 4) Biological Sample Repository (BSR). 5) Participate on
Committees, Subcommittees, and Working Groups to facilitate communications, coordinate activities across all
components of MoTrPAC, conduct continuous quality assurance of data, develop analytical strategies, and
prepare presentations and manuscripts to disseminate results.

Public health relevance
PROJECT NARRATIVE The proposed research aims to provide a comprehensive map of the protein “molecular transducers” that transmit the health benefits of physical activity by applying high throughput proteomics technologies. This project will be accomplished by a team and facility with an excellent record of accomplishment in applying and developing advanced mass spectrometry-based workflows and pipelines for proteomics research for human health applications.